Enhancing the IMHRD cohort to support study of the exposome in autoimmune disease

ABSTRACT
Systemic sclerosis (SSc) and Systemic lupus erythematosus (SLE, or lupus) are autoimmune diseases with
disproportionate prevalence and severity burdens among females of African ancestry (AA). Several
environmental risk factors are suspected to play a role; however, relationships are complex and difficult to
assess, thus much remains unknown. It is clear there is a critical need to improve studies of environmental
exposure and autoimmune disease. In response, NIH has released a Notice of Special Interest entitled:
“EXposome in Autoimmune Disease Collaborating Teams PLANning Awards (EXACT-PLAN)” intended to
advance the study of the exposome in autoimmune diseases. This project is designed to contribute to this effort
by establishing collaborations, study populations, and analytic approaches required to better characterize and
assess holistic environmental exposures in health studies on autoimmune disease. We are well positioned to
achieve this goal, as we leverage resources within the NIAMS-funded Improving Minority Health in Rheumatic
Diseases (IMHRD) Core Center for Clinical Research at the Medical University of South Carolina (MUSC), which
focuses on two autoimmune diseases, systemic sclerosis (SSc) and systemic lupus erythematosus (SLE), will
be leveraged. In addition, we present a strong research team with expertise in exposure science, epidemiology,
human population genetics, social epigenomics, and clinical research necessary to improve exposome research
on autoimmune disease. The overarching objective of this project is to improve understanding of how
environmental exposures influence autoimmune disease. Goals are to develop resources needed to address the
exposome within our study populations, develop innovative methodologies that will improve exposome studies,
and to establish our research group as a major contributor to national research efforts centered on the exposome.
The motivating hypothesis is that variability in environmental exposure (across the life course) is associated with
worse autoimmune disease outcomes. The first specific aim focuses on establishing a cohort within the IMHRD
study population that will support comprehensive characterization of the exposome. This also includes
recruitment of 100 additional participants to enhance our existing study population specifically for exposome
research. The second aim will develop novel data science tools to enhance integration and analysis of genetic,
environmental, epigenetic, and social measures across the life course. Accomplishing these aims will establish
a unique, health disparity cohort with autoimmune disease tailored specifically for exposome research, contribute
findings that will improve understanding of complex links between the environment and autoimmune disease,
and provide novel data science tools that will improve methodologies for analysis of the exposome.

Public health relevance
PROJECT NARRATIVE Establishing an EXACT-PLAN cohort site within the NIAMS-funded Improving Minority Health in Rheumatic Diseases (IMHRD) Core Center for Clinical Research, will provide a unique, study population with existing autoimmune health disparities that will advance study of the exposome. Methods development will center on high-dimensional exposure settings, aiming to provide tools that will improve both the characterizations of and statistical analyses involving numerous co-exposures in exposome research.